NPHCO Core

National Public Health Coordination Office (NPHCO)
Abstract
Serving as the National Public Health Coordination Office (NPHCO) 2021-2016, the UMMS
proposed program focus on driving collaborative engagement with public health entities,
promoting the use of NNLM’s resources and products. Program components include the Public
Health Digital Library (PHDL) program, coordinating and delivering training curricula for the
public health workforce and PHDL users, and forming a Public Health Collaborative (PHC) of
NNLM staff to develop training, communication outlets, and promotions for NNLM’s work with
public health on a national scale. As NPHCO, UMMS will work with the PHC to facilitate the
work of advancing engagement with the public health workforce. The program relies on
collaborative building of methods and processes that maintain values of consensus driven
agenda-setting, respecting diversity of voices and needs, and encourages public health to
engage in evidence-based practice, population-based frameworks, and recognizing social
determinants of health.

Public health relevance
National Public Health Coordinating Office Project Narrative Public Health Departments and agencies are on the front line for delivery of basic public health services to most of the communities in this country. The majority of health departments and agencies provide a wide variety of services to very diverse communities with limited resources and staff. The services provided vary widely from state to state, from urban to rural areas, and are especially adapted to address local priorities and concerns. Despite considerable variation, however, health departments provide essential services: adult and childhood immunizations; communicable disease control; community outreach and education; epidemiology and surveillance; environmental health regulation such as food safety services and restaurant inspections; and tuberculosis testing. The NPHCO program seeks to promote the use evidence- based information and NLM resources, including the Public Health Digital Library, to strengthen the capacity for research, practice, and continuing education.